Core C: Informatics-Genomics-Biostats Core

PROJECT SUMMARY/ABSTRACT - CORE C
The Informatics, Genomics, and Biostatistics Core (Core C) is a vital new addition to the Program Project Grant
(PPG) dedicated to unraveling the complexities of HTLV-1-induced adult T cell leukemia/lymphoma (ATLL). As
the research within the PPG advances to include sophisticated multi-omics techniques, Core C will provide
comprehensive bioinformatics and biostatistics support, essential for the success of all three interconnected
projects. The Bioinformatics component of the Core will support each project by offering expertise in study
design, omics data integration, data analysis, and visualization, as well as in the development of new
computational pipelines tailored to the specific needs of ATLL research. The Core's bioinformatics team,
experienced in genomics, transcriptomics, epigenomics, and single-cell RNA analysis, will leverage advanced
tools and techniques established in their labs. The Biostatistics component will ensure that robust statistical
methods are applied across all stages of the research process, from study design to final data analysis. This
includes the use of linear mixed models, ANOVA, and other advanced statistical techniques to handle the
complex experimental designs and large datasets generated by each project.
AIM 1. Provide bioinformatics and biostatistics support for PPG projects to ensure that robust statistical methods
and reproducible omics analyses are employed.
AIM 2. Provide bioinformatics and biostatistical training to Project lab trainees.
AIM 3. Development of new bioinformatics methods and algorithms needed to support or that derive from Project
analysis. Integration of viral and host multi-omics data at the single cell level is one example where new methods
will be created to drive the field forward.
These efforts will include the integration of viral and host multi-omics data at the single-cell level, providing new
insights into the mechanisms of viral pathogenesis and the development of novel therapeutic strategies. Through
these initiatives, Core C will play a central role in advancing the scientific goals of the PPG and contributing to
the broader field of cancer genomics.

Public health relevance
PROJECT NARRATIVE - Core C During recent decades, the development of large-scale data generation platforms and associated computational methodologies has resulted in an expanded role for bioinformatics and statistics experts in cancer research. The Informatics, Genomics and Biostatistics Core (Core C) will support the Retroviral Models of Cancer Program Platform Grant (PPG) by collaborating on all aspects of study design, quality control, computational resource use, analysis, interpretation and presentation of multi-omics data for all three PPG Projects. Finally, leveraging Core C faculty expertise in creating bioinformatics tools, we will develop and publicly release computational resources that facilitate integrative multi-omics analysis for retroviral models of cancer.